Defining WASp-dependent pathways in replication stress

Perturbation in the replication-stress response (RSR) and DNA damage response (DDR) causes
genomic-instability. Replication protein A (RPA) is a single-strand DNA (ssDNA) binding protein
with key roles in the RSR and DDR. Genomic-instability occurs in Wiskott-Aldrich syndrome
(WAS), a primary immunodeficiency and cancer susceptibility disorder, yet the molecular
underpinnings of unstable genome in WAS cells remain uncharacterized. WASp, the protein
deficient in this disorder, functions both in the cytoplasm and nucleus. In the nucleus, WASp
functions to prevent the accumulation of harmful R loops (RNA-DNA hybrids + ssDNA) and in the
pre-repair step of escorting broken DNA ends to the repair sites by the homology-directed repair
(HDR) pathway. Accordingly, WAS patient lymphocytes are poorly-equipped to both prevent and
resolve DNA damage, which proposes WAS as a “genotoxin-sensitive” immune dysregulation
disorder. Our foundational studies have uncovered an essential role of WASp in the RSR by
influencing RPA functions under hydroxyurea-induced replication stress, in both immune and
nonimmune cells. Therefore, the overall objective of this proposal is to explicate the molecular
details of how WASp safeguards normal replication and which proteins and pathways WASp
associates with to enable this function during replicative stress. We will test the hypothesis that
WASp is required to both prevent and manage replication stress and DNA damage. Specifically,
we will define WASp role in mechanisms that process a blocked replication fork (in Aim 1) and
address how WASp role specifically on modifying the actin state (G-actin vs. F-actin) influence
RSR (in Aim 2). Achieving these aims will propose WASp as a novel RSR factor, and human
WAS as a disease of dysfunctional RSR, which may provide new mechanisms for oncogenesis
in WAS.

Public health relevance
Wiskott-Aldrich syndrome (WAS) is associated with high mortality from infections, autoimmunity, and cancer. We have uncovered a new mechanism for disease causation that pertains to how WASp enables cells to manage DNA stress, which we will fully characterize in this project.